Resolving and understanding the genomic basis of heterogeneous complex traits and disease

ABSTRACT
Over the last decade, numerous large-scale biomedical studies have helped catalog hundreds of genomic
variants and physiological-clinical phenotypes associated with a range of complex traits and diseases. These
catalogs are now exposing wide chasms in our understanding of the mechanistic relationships between
genomic variation, cellular processes, tissue function, and trait variation – knowledge that is crucial for
advancing disease diagnosis and intervention. We develop and apply computational data-driven approaches to
bridge these gaps and help resolve, understand, and tackle the heterogeneity of complex traits and diseases.
We are specifically focusing on three key questions: 1) Each disease is not a single well-defined condition. Can
we deconvolve complex disorders into subtypes defined by shared functional dysregulations, and characterize
novel genes/mechanisms underlying each subtype? 2) Most diseases vary in prevalence and impact between
males and females, and across life stages. Can we delineate the genomic basis of differences in tissue
physiology and disease between sexes and across ages? 3) Choosing the right in vivo system to study human
diseases is hard due to murky relationships between phenotypes/genes in humans and model species. Can
we systematically identify functionally `analogous' genes, phenotypes, and conditions in model organisms for
studying specific facets of complex traits/diseases? To address these critical questions across diseases, we
will develop a suite of computational frameworks that integrate genomic data collections, fragmented prior
knowledge, and individual-/population-level genotypes-phenotypes. We will use this approach to systematically
unravel genomic signatures, pathways, and networks that help characterize mechanistic subtypes, age/sex
biases, and cross-species analogs of a wide range of diseases. We have established collaborations for
experimentally following-up our predictions for specific test cases including autism, gastrointestinal disorder,
coronary artery disease, cardiomyopathies, abnormal pregnancy, and eating disorders. Together, this
concerted effort will help us gain insights into the multi-scale mechanisms underlying heterogeneous traits and
diseases. In the long-term, our frameworks and mechanistic insights will enable us to link an individual's
genomic profiles to a precise assessment of her/his physiological traits, disease risks, and clinical outcomes.

Public health relevance
NARRATIVE We are proposing to develop a suite of computational frameworks that integrate massive collections of genomic and biomedical data to unravel disease subtypes, age/sex biases, and cross-species analogs of a wide range of complex disorders. The methods and results from this project will help us gain insights into the multi-scale mechanisms underlying the heterogeneity of traits and diseases. In the long-term, our frameworks and mechanistic insights will enable us to link an individual's genomic profiles to a precise assessment of her/his physiological traits, disease risks, and clinical outcomes, and thus usher in the era of precision medicine.